The Health for Hearts United Collaborative

Program Director/Principal Investigator (Last, First, Middle): Ralston, Penny A.
The Health for Hearts United Collaborative
Project Summary
Cardiovascular disease (CVD) is the leading cause of death in the United States, and disproportionately affects
African Americans (AAs) who have the highest rates for CVD-related morbidity and mortality in comparison to
other ethnic/racial groups. Risk factors for these high CVD rates are related to a variety of factors, including
lifestyle. Church-based interventions have been shown to be effective in improving physical health outcomes of
AAs. However, a critical barrier to advancing the science of church-based health is understanding the most
effective strategies and the extent to which evidence-based health programs can be implemented and
maintained by churches themselves The Health for Hearts United Collaborative (HHUC), a community-
academic partnership comprised of 45 churches in collaboration with a broader multi-county health coalition,
was established after two successful intervention studies to reduce CVD risk in AAs in a two-county area of North
Florida, using community-based participatory research approaches. We now seek to use this collaborative
environment to investigate implementation of this intervention by the churches themselves as we expand the
HHUC. Thus, the proposed project will determine the effectiveness of HHUC implementation strategies
in relation to process outcomes and reducing CVD risk in AAs, guided by ecological theory, the
Consolidated Framework for Implementation Research (CFIR), and the RE-AIM framework, and using a two-
phase approach. The HHUC model currently includes three components: governance structure, annual events,
and basic support. Based on observed successes in selected HHUC churches, we propose adding a fourth
component that includes one of two possible implementation strategies: 1) an internal champions (IC)-driven
strategy that includes two features (leadership development, culturally-tailored planning approaches) or 2) an
external change agent (external professionals [EP])-driven strategy without these features. In Phase 1, we will
pilot and refine the IC and EP-driven implementation strategies using health leaders from four churches in
the two-county area by determining feasibility and acceptability. In Phase 2, we will use an effectiveness-
implementation hybrid Type 3 design to evaluate the IC and EP implementation strategies in relation to
process outcomes (reach, adoption, implementation and maintenance); and individual health behaviors (food
choice, dietary quality, physical activity) and clinical outcomes (BMIs, girth circumferences, systolic and diastolic
blood pressure), using congregants ((>18, n=225) in nine churches in the two-county area: three IC treatment,
three EP treatment, and three comparison with delayed comparable activities. The findings from this study will
inform the expansion of the HHUC and the reduction of CVD risk in AAs, with implications for other communities
and regions in the U.S.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Ralston, Penny A. Project Narrative African Americans have higher heart disease and stroke-related morbidity and mortality in comparison to Non- Hispanic Whites and other ethnic/racial groups. Church-based health interventions have shown improvement in health behaviors and clinical outcomes, yet there is limited research available that evaluates the extent to which churches themselves can implement these interventions. This proposed project will determine the effectiveness of HHUC implementation strategies in relation to process outcomes and reducing CVD risk in African Americans, examining two possible strategies. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page